Helping Veterans understand their providers' notes with Chatbot-NoteAid

Helping Veterans understand their providers’ notes with Chatbot-NoteAid
Background: Allowing patient access to their providers’ notes (OpenNote) helps enhance
disease understanding, patient-provider communication, medication safety, self-managed care,
and health outcomes. However, many patients do not understand their electronic health record
(EHR) notes.
Significance: Diabetes affects 25 percent of the VA patient population. The disease is also the
leading cause of visual impairment. While physicians face burnout and have limited time for
patients, few computational interventions exist to help improve patient education.
Innovation & Impact: We will therefore build Chatbot-NoteAid to help mitigate the challenges.
Open-domain systems (e.g., GPTs) may be used for education; however, they are not HIPAA
compliant and have concerns in hallucination. Chatbot-NoteAid will overcome these limitations.
Communication is the central process of education. Chatbot-NoteAid will help patients
understand clinical notes with learning as conversation technology, where patients do not read
their notes but will gain information and knowledge through conversation with Chatbot-NoteAid.
In addition to helping Veterans with low vision, compared to the traditional learning by reading,
learning as conversation has the advantages that conversation helps patients stay engaged and
that information is provided piece by piece, which helps strengthen learning.
Specific Aims: Aim 1: We will develop Chatbot-NoteAid using innovative NLP for empathy and
patient engagement, and user-centered design and usability testing. We will implement Chatbot-
NoteAid using FHIR, the standard for health information exchange. Aim 2: We will build a novel
instrument for note-level comprehension so that the instrument can be used to quantitatively
evaluate whether Chatbot-NoteAid improves patients’ note comprehension in Aim 3. Aim 3: We
will evaluate whether Chatbot-NoteAid improves EHR note comprehension in patients with
diabetes in a pilot study.
Methodology: We will develop Chatbot-NoteAid technologies using methods to engage
patients in conversation, user-centered design, and usability testing. Chatbot-NoteAid will
generate a comprehensive list of questions specific to a patient’s note and will check the
accuracy of the patient’s answer. We will develop Chatbot-NoteAid with user-centered design
and usability testing. A novel literacy instrument will be developed to quantitatively evaluate
whether Chatbot-NoteAid improves patients’ note comprehension. We will conduct a pilot
evaluation to assess the feasibility, acceptability, and impact of Chatbot-NoteAid with 32
patients.
Next Steps/Implementation: Results will be used to design a future implementation trial to
assess comprehension, and behavioral and clinical outcome changes in the Veteran population.

Public health relevance
Helping Veterans understand their providers’ notes with Chatbot-NoteAid Allowing patient access to their providers’ notes (OpenNote) helps enhance disease understanding, patient-provider communication, medication safety, self-managed care, and health outcomes. However, many patients do not understand their electronic health record (EHR) notes. In this proposal we develop Chatbot-NoteAid, a novel multi-component learning- through conversation AI system that helps patients understand their providers’ notes without reading the notes. We will also develop a novel literacy instrument for note-level comprehension to evaluate whether Chatbot-NoteAid improves patient comprehension. We will recruit 32 patients for both quantitative usability testing and pilot evaluation.